Regulation of Steady-State Hematopoiesis by Microbiota-Driven IFN-I Signaling

Abstract/Project Summary
Over 200 million courses of antibiotics were prescribed in the U.S. in 2020, raising a significant clinical concern
as antibiotic courses of two weeks or longer result in hematological complications, the most serious of which is
neutropenia. Neutropenia, if left untreated, is a risk factor for subsequent infections, sepsis, and death.
Elucidating the molecular mechanisms of antibiotic-associated bone marrow suppression will allow us to develop
therapies to prevent or treat bone marrow suppression in patients who require prolonged antibiotics.
Our lab has developed a mouse model of antibiotic-associated bone marrow suppression that showed
that depletion of the microbiome on prolonged antibiotics results in anemia, leukopenia, and other cytopenias.
However, the precise stage in differentiation at which antibiotics disrupt hematopoiesis remains unknown. We
further demonstrated that the microbiome promotes a basal level of type I interferon (IFN-I) signaling, which is
required to maintain steady-state hematopoiesis in a STAT1-dependent manner. Although prior studies showed
that activation of NOD1 and TLR-MYD88 pathways can support myelopoiesis, I observed normal numbers of
hematopoietic progenitors and granulocytes at baseline in Nod1 and Myd88-deficient mice, suggesting that these
pathways are dispensable for normal blood production. Several independent studies have shown that the
microbiome can induce tonic IFN-I signaling through TLR-TRIF, cGAS-STING, and RIG-I-MAVS pathways,
though their contribution to hematopoietic maintenance is not well understood. In an untargeted metabolomics
screening, we identified 29 microbial metabolites that were enriched in stool and serum samples from non-
leukopenic mice compared to those that were leukopenic two weeks post-antibiotics. Whether these metabolites
can support hematopoiesis in vivo remains unexplored. This proposal will test the hypothesis that the microbiome
utilizes immune-related signaling pathways such as TLR-TRIF, cGAS-STING, and RIG-I-MAVS pathways to
support IFN-I mediated steady-state hematopoiesis at the level of the hematopoietic stem cell (HSC).
A major limitation of our prior work is that a shift in Sca-1 expression caused by IFN-I suppression could
have skewed the enumeration of HSPCs in antibiotic-treated mice. To address this, we will first perform a limiting
dilution transplant to quantify functional HSCs in antibiotics and mock-treated mice. We will also trace the fate of
HSPCs and granulocyte populations by tracking their proliferation, differentiation, and turnover in Krt18-
CreERT2:Rosa26-lox-STOP-lox-TdTomato mice treated with or without antibiotics. To elucidate the mechanism
of microbiome-dependent hematopoiesis, we will characterize the hematopoietic defects in Trif-/-, Sting-/-, and
Mavs-/- mice treated with or without antibiotics. We will validate our results by assessing the sufficiency of TLR,
STING, and RIG-I agonists to rescue antibiotic-associated hematopoietic defects. We will also use IfnbΔβ-luc/Δβ-luc
reporter mice to evaluate the ability of microbial metabolites to sustain basal IFN-I production. These studies will
define the mechanisms by which the microbiome promotes IFN-I production to regulate hematopoiesis.

Public health relevance
Project Narrative Prolonged use of antibiotics impairs normal blood production by depleting the microbiome. Here, we propose to investigate the effects of prolonged antibiotics on hematopoietic progenitors and granulocyte populations and identify the microbiome-driven immune signaling pathways and metabolites that promote normal hematopoiesis.